Predoctoral Training Program in Chemistry and Biology

PROJECT SUMMARY/ABSTRACT
The landscape of biomedical research is changing rapidly due to major technological and conceptual
advances, creating new research opportunities and expansion in the scope of occupations while posing
challenges for graduate training in quantitative and multidisciplinary science. Furthermore, an emphasis on
best practices in graduate education and mentorship has emerged from socioeconomic shifts. To respond to
these ongoing developments and the needs of students and the broader society, the Department of
Biochemistry & Molecular Biology (BMB) and the Department of Chemistry (Chem) at The University of
Chicago propose an interdisciplinary, predoctoral training program directed at the interface of the chemical and
biological sciences (CBI) that aims to recruit, educate and train a diverse, new generation of biomedical
scholars by deploying new best practices in training, mentoring, and education to promote rigorous cross-
disciplinary research while developing quantitative literacy and maintaining depth in the core discipline, thereby
preparing them for success in careers that require scientific training. The program benefits from outstanding
faculty and students and introduction of new courses in interdisciplinary science. The 25 training faculty
consists of twelve faculty with appointments in BMB (one with a joint appointment in Chemistry), ten faculty in
Chemistry (one with a joint appointment in BMB), two in the Ben May Department for Cancer Research, and
one in Molecular Engineering. Strategies to develop cross-disciplinary training include: (1) satisfactory
completion of a core course in Chemical Biology and a breadth course in the department of the other scientific
discipline; (2) cross-disciplinary thesis research; (3) participation in a series of monthly meetings throughout
the academic year designated as "Integrative Discussions at the Interface of Chemistry & Biology" to gain
acquaintance with theoretical concepts and methods; (4) participation in two quarterly meetings focused on
advanced chemical tools in biology (ACT-Bio) and biological problems that require chemical solutions
(BPRCS); (5) participation in two in two annual half-day events: a CBI Minisymposium and an “in-house” poster
retreat; and (6) workshops to promote quantitative literacy and rigor and reproducibility. Participation in a
division-wide career development program helps students explore and prepare for different career paths.
The broad scope of the interdisciplinary research interests of the faculty strengthened through collaborative
research and teaching ensures a wide variety of opportunities for meaningful cross-training. The program will
promote excellence in mentorship through more frequent advising, mentoring compacts and required annual
faculty mentorship training. Through active participation in pipeline, outreach, and bridge programs, and
through participation in graduate admissions and faculty recruitment, program faculty will promote the
recruitment and retention of an increasingly diverse scientific community. An external advisory committee and
professionally implemented evaluation instruments will guide improvements to the program.

Public health relevance
PROJECT NARRATIVE The Chemical and Biology Interface (CBI) Training Program at University of Chicago trains students to work at the interface of chemistry and biology and to apply rigorous approaches with quantitative literacy to solve problems in biomedical science, equipping them with the scientific, communication, professional, and career navigating skills to make significant contributions to society in academic or research-related careers.